KUH-TN Professional Development Core

The goal of the Professional Development Core is to enhance trainee competitiveness in research by
structuring and facilitating professional development for both the trainees and their mentors. The program we
have outlined will provide the necessary training to ensure the acquisition of knowledge and skills needed to
navigate a research career successfully. This goal will be achieved by:
1. 6 Strategic Approaches. A Core Curriculum comprised of biweekly seminars will be implemented over
the 2 years of training with presentations on a variety of topics,
2. Elective Courses for Additional Professional Development offered by CWRU and its affiliated institutions,
will be made available to trainees to gain a more in depth understanding of areas.
3. Individualized Professional Development Mentoring provided to each trainee by a professional
development mentor, in addition to their research mentor.
4. Mentoring the Mentors will be accomplished by assigning each trainee mentor their own mentor from
among the U2C leadership who are very experienced mentors.
5. Using Social Media and Technology to Advance Professional Development will be the focus on topics
such as using social media to enhance professional networking and visibility and using online
technologies to facilitate research.
6. Self-Evaluation of the Professional Development Core will be accomplished using a set of defined
procedures.
The Professional Development Core is led by a team of 3 accomplished scientists (Drs. Damaser, Dell and
Rahman), who are all full Professors, experienced mentors and active in national research networks and
organizations. The team members bring complementary expertise in basic, translational and clinical research,
and insight into Professional Development. With its Strategic Approaches and coordinated efforts, the
Professional Development Core will provide a nurturing environment to foster trainees' growth into successful
independent researchers. Our proposed interdisciplinary program harnesses a robust mentoring environment,
innovative technology, and critical research resources with both tailored and structured educational experiences.